Impact of sex differences on the trajectory of interactome dysfunctions across the AD spectrum

ABSTRACT
The impact of sex differences in Alzheimer's disease (AD) remains poorly understood, especially in the context
of protein-protein interactions within vulnerable regions that drive dysfunction. Despite growing appreciation of
the clinical course, presentation, and severity of AD, studies of sex impacting AD development and progression
are lacking. Although recent high-throughput and bioinformatics technologies help to understand molecular and
genetic basis of sex differences in aging and AD, reliance on static `omics data representing a descriptive
inventory of biomolecules measuring changes in their stoichiometry at a given time and condition limits functional
insights. Another roadblock is translating these complex datasets into biological insights requires sophisticated
computational algorithms, diminishing access and impact to the biomedical community at large.
To address these limitations this proposal introduces epichaperomics, an unbiased state-of-the-art `omics
approach we invented to generate direct access to interactome perturbations and to the functional outcome of
such changes in native biological systems. We posit by applying epichaperomics to well-characterized
postmortem human brains that i) capture the disease trajectory, ii) encompass AD vulnerable and less affected
regions, and iii) have robust parallel information on patient-specific correlates, will enable rigorous hypothesis-
generating analyses on potential impact of stressors and vulnerabilities on disease trajectory, and on interactome
as well as connectome dysfunctions as they occur in sex-dependent manner. Through this novel approach we
expect to derive mechanistic innovation on specific dysfunctions impacted by sex differences leading to insights
into sex-phenotype relationships not available through other `omics platforms. By evaluating, understanding, and
anticipating interactome changes through epichaperome formation in relation to sex impact (Aim 1) and
subsequent straightforward computational analysis with web-based output (Aim 2), first-of-a-kind proteome-wide
insights into the impact of sex differences on interactome networks vulnerabilities and dysfunctions within the
hippocampus and regions of the default mode network in relation to the relatively spared cerebellum, both on
their nature and trajectory, in vulnerable cells and brain regions will be generated. Information how stressors and
vulnerabilities (e.g., genes, environment, hormonal status) interact at cell and brain connectome levels to
produce heterogeneous phenotype mapping of disease vulnerability will be produced. We posit a whole new
treatment paradigm avenue will open, providing a previously unavailable sex-specific precision medicine
approach to AD by understanding and targeting the interactome across the AD spectrum of no cognitive
impairment, mild cognitive impairment, and AD dementia through stressor and vulnerability analysis. Raw
datasets and data analytics from interactome network studies will be deposited into free-access portals
accessible by the scientific community for additional mining and hypothesis testing studies. A web-based user-
interface will also be designed facilitating data processing and visualization.

Public health relevance
NARRATIVE Understanding mechanisms underlying sex-related vulnerabilities relevant to Alzheimer's disease (AD) from cells to networks is critical to interrogate disease processes and develop effective sex stratified, precision medicine derived therapies. We present an innovative, multidisciplinary strategy to study proteome-wide protein-protein interactions in disease to investigate interactome network and connectome dysfunction in the context of sex- specific vulnerabilities in brain cells and regions across the AD spectrum. Outcomes are highly relevant insights underlying sex difference driven molecular mechanisms and the influence of differential risk factors negatively impacting brain function at the cell, network, and connectome levels as they relate to the transition from healthy aging to pathologic neurodegeneration, topics of high interest under RFA-AG-21-029.